Role of Eosinophils in Hepatic Ischemia Reperfusion Injury

PROJECT SUMMARY
The goal of this proposal is to investigate the functional role of eosinophils during hepatic ischemia and
reperfusion injury (IRI). Hepatic IRI is a significant source of morbidity and mortality during major hepatic
resection and during liver transplantation. Previous studies have shown that following liver transplantation
innate immune cells, such as neutrophils or macrophages, are activated and traffic into the hepatic allograft.
Unexpectedly, we observed that eosinophils also accumulate in the liver following orthotopic liver
transplantation in humans. In contrast, we could not detect any eosinophils in healthy liver biopsies. Similarly,
in a murine model, eosinophils accumulate in the liver in a time-dependent fashion following hepatic IRI.
Functional studies using genetic and antibody-based depletion of eosinophils demonstrate a protective role of
these cells during hepatic IRI. An unbiased screen of gene expression profiles following eosinophil depletion
implicated eosinophil-dependent ST2 in liver protection. Combination of genetic and adoptive transfer studies
suggest that eosinophil-specific IL-33/ST2 signaling attenuates inflammation of the ischemic liver by
dampening hepatic neutrophil accumulation/activation. These findings led to our hypothesis that during
hepatic IRI, eosinophils protect the liver through IL-33/ST2 signaling. Three Specific Aims are proposed
to i) investigate the role of eosinophils and IL-33/ST2 signaling in hepatic IRI, ii) elucidate the mechanism by
which IL-33/ST2 signaling in eosinophils protects against hepatic IRI, and iii) Target IL-33/ST2 signaling in
eosinophils for the treatment of hepatic IRI.

Public health relevance
PROJECT NARRATIVE Our studies are designed to lay the groundwork for novel therapeutic approaches for treating patients who are suffering from acute hepatic ischemia and reperfusion injury, for example during cadaveric liver transplantation, living-donor-related liver transplantation or major liver resection. Our studies point towards a novel role for eosinophils and its IL-33/ST2 signaling in protection against hepatic ischemia reperfusion injury. If successful, our studies will contribute to preventing or treating hepatic ischemia and repefusion injury – one of the leading causes of morbidity and mortality of liver surgery and liver transplantation.